Optimizing Time-Limited Trials of Mechanical Ventilation in Acute Respiratory Failure: A Mixed Methods Observational Study

ABSTRACT
Current intensive care unit (ICU) care delivery for acute respiratory failure fails to meet the needs of patients
near the end of life, their families, and their interprofessional ICU teams. Efforts to improve end-of-life ICU care
have focused on communication between families and clinicians. Yet, poor end-of-life outcomes for patients,
families, and ICU teams remain intractable, in part because of the system-level processes and norms that drive
ICU care delivery. Time-limited trials have promise to disrupt system-level drivers of poor quality end-of-life
care and establish processes of care delivery that better support patients, families, and ICU teams. A time-
limited “trial” is an agreement among patients, their surrogate decision makers, and clinicians to attempt life-
sustaining treatment for a predefined period and then re-evaluate its utility. This patient care model was
proposed by palliative care experts to address prognostic uncertainty, and navigate competing desires
simultaneously held by many patients—to extend life when possible and to avoid prolonged life-sustaining
treatment if the chance of recovery is low. Time-limited trials have been described in the literature, endorsed by
palliative and critical care professional societies, and are currently used in ICU practice. Yet, time-limited trials
remain poorly formalized in practice with little evidence to guide ICU clinicians in how to conduct trials.
The central objective of this study is to define the optimal care delivery processes of a time-limited trial in acute
respiratory failure. This application responds to NHLBI’s Notice of Special Interest in Palliative Care (NOT-HL-
20-737), including the focus on models of ICU-based palliative care for acute respiratory failure and on how
ICU structure and culture influence palliative care delivery. This project is a sequential mixed methods,
prospective observational study in five ICUs where time-limited trials are currently used. In Aim 1, focused
ethnography of 50 time-limited trials in patients with acute respiratory failure will be used to map current
processes of time-limited trial care delivery for patients with acute respiratory failure. In Aim 2, a prospective,
observational cohort study in 5,810 patients with acute respiratory failure will be used to elucidate the
relationships between time-limited trial processes and end-of-life outcomes for patients, surrogates, and ICU
teams. Aims 2a and 2b will test whether time-limited trial processes are associated with better end-of-life
outcomes and Aim 2c will characterize mechanisms by which processes influence end-of-life outcomes.
This work will transform time-limited trials from a promising model into a clearly defined and optimized care
delivery process. This process will be immediately actionable to guide frontline ICU teams currently using or
considering time-limited trials. This study will also establish the necessary foundation for the design and testing
of complex health interventions that support time-limited trials and safeguard against unintended harms.

Public health relevance
PROJECT NARRATIVE Healthcare provided in intensive care units often fails to meet the needs of patients who are near the end of life, their families, and their clinicians. This study will investigate a new model of care for patients with respiratory failure called a time-limited trial, which includes a trial of life support, clear milestones, and a timeline to help evaluate whether the patient is recovering. The knowledge generated in this proposal will be used to ensure medical decisions for patients with respiratory failure reflect their individual goals, values, and priorities, and can be extended to patient populations with other serious illnesses in the future.